CORE A ADMINISTRATIVE

The Administrative Core does the accounting, record keeping, purchasing, preparation of continuation reports and final drafts of manuscripts, seminar, meeting, and travel arrangements, and other reporting required for this Program and assists the PD in tracking oversight and compliance. Most of this activity is supported by the Institute of Neuroscience; the Program supports 15% of a Grant Administrator, 20% of an Office Specialist and 10% of the PD's salary.

Public health relevance
The aims of this Program Project Grant are to understand the developmental basis of phenotypic variation in three human diseases, Fraser syndrome. Usher syndrome and Hirschsprung disease. The four Core Units ~ Administration, Microimaging, Technical Support and Zebrafish Facility ~ provide the administrative and technical support required to accomplish the Aims of the Component Projects within this Program Project Grant.